Long-term Trauma Outcomes and Insurance Policy

PROJECT SUMMARY/ABSTRACT
Though trauma is often considered an isolated disease process, advancements in acute care have shifted the
burden of injury from the acute physiologic insult to the chronic post-injury sequalae. Over 95% of hospitalized
trauma patients now survive to discharge. However, many go on to suffer long-term consequences of injury in
the form of worsened functional status, mental health, and health-related quality of life. These trauma-initiated
chronic conditions make it difficult for many working-age adults to return to work and economic productivity.
The combination of poor clinical outcomes and work loss may be further compounded by unexpected medical
debt as many working-age adults carry high-deductible insurance plans. Unfortunately, there is a paucity of
information regarding long-term clinical and economic outcomes after major injury in the US. As a result, the
policy interventions needed to optimize long-term recovery after major injury remain unknown. The purpose of
this proposal is to close these key knowledge gaps and map a policy response moving forward. The specific
research aims of this proposal are to evaluate (i) long-term clinical outcomes and (ii) long-term economic
outcomes among working-age survivors of traumatic injury; and to evaluate (iii) the impact of alternative
insurance design strategies on long-term outcomes after traumatic injury. The proposed study leverages a
unique data opportunity at our institution and will be the first of its kind to combine a state-wide trauma registry
(containing both inpatient data and long-term patient-reported outcomes) with 24 months of pre-injury and 24
months of post-injury consumer credit reports. We will use the evidence from these novel analyses to simulate
changes in insurance benefit design in order to optimize return to work and mitigate financial strain after injury.
This project will also facilitate the career development of the candidate. The highly experienced and
multidisciplinary mentorship team, the proposed career development and research plan, and the unparalleled
research environment are ideally suited to address the career goals and educational needs of the candidate PI,
John W. Scott, MD, MPH. Although he has substantial prior experience in surgical health services research, he
lacks experience with (i) longitudinal data analysis, (ii) evaluating personal financial data, and (iii) policy
simulation methods. In addition to the innovative research plan, this proposal also includes additional training
which will be essential both for the successful completion of this research and for Dr. Scott’s career
development, including graduate level courses and experiential learning opportunities. This career
development award will lay the groundwork for Dr. Scott to mature as an independent investigator and national
leader in improving long-term clinical and economic outcomes after acute illness and injury through policy
evaluation and reform.

Public health relevance
PROJECT NARRATIVE This project will examine the long-term clinical and economic outcomes among working-age survivors of traumatic injury by leveraging a unique data opportunity to combine our statewide trauma registry with commercial credit reports. We will then use policy simulation techniques to evaluate the impact of alternative health insurance design strategies on financial strain and health-related quality of life. Understanding the drivers of poor long-term outcomes and the potential impact of insurance policy redesign will help clinicians, researchers, and policymakers optimize long-term recovery after acute illness or injury.